Optimization and mechanisms of electrical neurostimulation in mouse models of epilepsy

PROJECT SUMMARY/ABSTRACT
Drug-resistant epilepsy affects approximately 1 million people in the United States. Responsive neural
stimulation (RNS) and deep brain stimulation (DBS) offer novel treatment options for refractory seizures. These
neurostimulation therapies have significant advantages over surgical resection, though they are generally less
effective. Treatment optimization has been challenging due to inter-patient variability, electrode placement, and
the vast range of available stimulation parameters. This project aims to provide a more comprehensive
description of the spatial and temporal dynamics that underlie neurostimulation and evaluate novel therapeutic
effects that could prevent and modify the disease course in epilepsy.
This proposal also outlines a five-year career development program focused on acquiring the skills necessary
to perform an in-depth mechanistic analysis of neurostimulation in a rodent model of temporal lobe epilepsy.
Washington University provides an excellent environment of collaborators and resources to develop skills
necessary for investigating neurostimulation as a treatment modality for epilepsy. The outlined proposal builds
on Dr. Foutz's prior research in deep brain stimulation and his clinical training in the field of epilepsy. Under the
mentorship of Michael Wong, M.D., Ph.D. (basic scientist, clinical epileptologist), and Dominique Durand, Ph.D.
(basic scientist, biomedical engineer), he will investigate the spatiotemporal dynamics underlying electrical
neurostimulation and evaluate anti-epileptogenic effects. Dr. Foutz has a career goal to become a translational
scientist focused on developing and optimizing device-based neuromodulatory treatments for patients with
epilepsy. The career development plan outlines formal and informal training in animal models of epilepsy and
neurostimulation. This work's potential impact is to optimize existing devices, guide the development of next-
generation neurostimulation technology and discover novel therapeutic effects of neurostimulation in epilepsy.

Public health relevance
PROJECT NARRATIVE Drug-resistant epilepsy is a devastating neurological disorder that afflicts approximately 1 million people in the United States who have limited effective treatment options. Brain stimulation is a novel therapy for epilepsy that is adjustable and generally well-tolerated; however, the optimal protocols and underlying mechanisms of neurostimulation in epilepsy remain unknown. The proposed study will explore the temporal and spatial optimization of neurostimulation in epilepsy, and investigate its novel mechanistic effects on disease evolution with the ultimate goal to improve neurostimulation therapy and the lives of people with epilepsy.